California National Primate Research Center

Summary
The COVID-19 pandemic constitutes a significant challenge to health care systems in the United States and
abroad. A systemic compromise of the organism following SARS-CoV-2 infection has emerged as an important
factor associated with COVID-19 severity, disproportionally affecting older patients with comorbidities such as
hypertension, diabetes, and dementia. In addition to respiratory symptoms, COVID-19 patients can present
neurological symptoms, ranging from the frequent loss of smell to rare but severe neurovascular and
neuroinflammatory events. These neurological symptoms disproportionally affect patients with Alzheimer’s
disease (AD) and can potentially lead to clinical scenarios previously associated with faster neurodegenerative
progression and worse behavioral outcomes. The involvement of the brain during COVID-19 and the
mechanisms of interaction between SARS-CoV-2 and AD pathological routes, however, remain poorly
understood. Our long-term goal in this project is to further our knowledge on how neuropathology may contribute
to the complex clinical presentation of COVID-19 and how SARS-CoV-2 infection and AD can negatively
synergize in vulnerable patients. The objective of this grant is to characterize the short-term effects of SARS-
CoV-2 in the brain during the acute stage of the infection in both young and aged diabetic animals, and a possible
protective effect of immunotherapeutic prophylaxis. The central hypothesis is that SARS-CoV-2 is both
neuroinvasive and neurotropic, accessing the brain and infecting neurons and potentially other cells within the
CNS, leading to neurodegeneration, inflammation, and a brain environment conducive to dementia. The rationale
is that other human coronaviruses are neuroinvasive and neurotropic, including the closely related SARS-CoV-
1, causing direct damage to neurons and myelin and triggering neuroinflammatory processes. Furthermore, the
SARS-CoV-2 entry receptor ACE2 has been previously implicated in AD, and other coronavirus infections have
been reported to trigger adaptive intracellular cascades linked to neurodegeneration. Our specific aims will test
the following hypotheses: (Aim 1) SARS-CoV-2 is neuroinvasive, neurotropic, and its infection of brain cells
causes neuronal and myelinic damage; (Aim 2) SARS-CoV-2 infection triggers neuroinflammation and cytokine
release, and prophylactic treatment with immunotherapeutic agents, such as convalescent plasma and
monoclonal antibodies, can affect the brain response; (Aim 3) COVID-19 and AD neuropathological routes
interact directly at the molecular level through the regulation of ACE2 and stress response pathways. This
contribution is significant as it will considerably advance our knowledge of COVID-19 pathology, opening new
avenues of treatment and care for a major public health concern, while also providing the necessary framework
to understand the long-term consequences of COVID-19 and its impact on AD pathology. The proposed research
is innovative in its use of a highly translational non-human primate model to reveal the neurobiological aspects
of viral infections.

Public health relevance
Project Narrative Individuals living with dementia, including Alzheimer’s disease, are disproportionally likely to develop and die of COVID-19, but we still do not understand how the two diseases interact. In this project, we propose to use a highly translatable monkey model to investigate how SARS-CoV-2 affects the brain in young and older subjects with comorbidities, including how the viral infection can potentiate neurodegeneration. Our non-human primate model provides a unique opportunity to reveal the interplay between viral infections and the brain and investigate therapeutic strategies.